Effects of per- and polyfluoroalkyl substances on placental features and size at birth

PROJECT SUMMARY
Per- and polyfluoroalkyl substances (PFAS) are ubiquitous and highly persistent chemicals, that have been
used widely in industry for seven decades and are known to adversely influence maternal and child health.
PFAS have recently become a public health priority evidenced by President Biden’s call to action to prevent
the adverse impacts from PFAS present in our air, water, and food supply. Achieving this goal necessitates
monitoring a broad range of PFAS and determining the health effects of realistic scenarios of exposures to
PFAS mixtures, though most prior research has investigated PFAS one at a time. Moreover, data are needed
to inform national policies, and clinical guidelines can only be determined by studying the most susceptible
populations, namely pregnant women and newborns. Therefore, to inform national policies and clinical
guidelines, we propose to investigate the risks associated with prenatal exposure to PFAS in the New
Hampshire Birth Cohort Study, a large rural U.S. cohort of over 2,400 mother-infant dyads with anticipated
enrollment of 3,000. We will investigate the effects of PFAS, measured in maternal blood during pregnancy, on
placental features and birth size, which is a sentinel outcome, with both insufficient and excessive fetal growth
contributing to infant morbidity and mortality and enduring risk of cardiovascular and metabolic morbidity well
into adulthood. We will leverage extensive extant data from our decade-long cohort, including toxicant
exposure and clinical metadata. We will test the hypothesis that PFAS, alone and as mixtures, adversely affect
placental features and reduce size at birth. Further, we will explore whether associations of PFAS with size at
birth are mediated by the influence of PFAS on the placenta. Our work will integrate advances in statistical
methodologies for evaluating exposure mixtures and evaluate PFAS for which effective federal regulations do
not yet exist.

Public health relevance
Project Narrative Emerging data indicate that exposure to relatively low levels of contaminants during pregnancy may adversely affect placental and fetal development. This project will extend our rural U.S. pregnancy cohort to investigate the effects of toxicants in our drinking water and diet on placental features and birth size and generate the necessary knowledge to inform policies and clinical practices geared at improving the health and well-being of women and children.